Mechanisms of Recombinational DNA Repair

Project Summary/Abstract
Homologous recombination maintains genomic stability through high-fidelity repair of double-strand DNA breaks
and other complex DNA damage that is induced directly or indirectly by common anti-tumor agents including
ionizing radiation, topoisomerase-targeted drugs, interstrand crosslinking agents, and those causing stalling of
replication forks. Homologous recombination defects bear dual significance for cancer by first leading to genomic
instability and increased cancer predisposition. Moreover, recombination defects cause specific cellular
vulnerabilities that can be exploited therapeutically either by traditional DNA damage-based treatment or by
targeted treatment (e.g., poly(ADP-ribose) polymerase inhibition). The same genome-preserving mechanism
contributes to genomic instability and genome evolution through non-allelic homologous recombination between
repeated DNA elements. The objectives of this R35 MIRA are to study the mechanisms of how homologous
recombination maintains genomic stability, and how it induces genome rearrangements between repeated DNA
sequences using biochemical, structural biology, genetic, cell biological, and genomic approaches. Our research
uses the budding yeast Saccharomyces cerevisiae as the lead model to establish fundamental paradigms that
we are transferring to human proteins, cells, and tumor genomics. We have developed new experimental tools
to detect recombination intermediates and products that close important gaps in the toolbox to study
recombination. We propose to expand these tools and adapt them to human cells. Building on substantial
preliminary data, we will continue to address unresolved questions regarding the dynamic processing of
displacement loops, a central recombination intermediate; and the roles of the double-stranded DNA motor
proteins RAD54 and RAD54B in homologous recombination. We have discovered multi-invasion intermediates,
where a single Rad51-single-strand DNA filament pairs with multiple donor loci, leading to a cascade of genomic
rearrangements. We propose to define the mechanisms resolving such multi-invasion intermediates and define
their mutagenic impact. More broadly, we will define the mechanisms and regulation of non-allelic homologous
recombination. We will establish how mismatch repair functions in quality control to avoid recombination between
near-identical repeats and establish the significance of this process for human tumor biology by analyzing
genomes of mismatch repair-deficient tumors (Lynch Syndrome) for signatures of hyper-recombination between
repeated DNA elements and multi-invasion-mediated rearrangements.

Public health relevance
Project Narrative The proposed project will lead to an improved mechanistic understanding of the homologous recombination DNA repair pathway and its ability to repair DNA damage as well as remodel genomes. Homologous recombination reshapes genomes during meiosis, evolution, and ontogenic development affecting fertility, speciation, and human disease, especially cancer. Homologous recombination is a pivotal tumor suppressor pathway that maintains genomic stability and is critical in repairing DNA lesions induced by ionizing radiation and other common modalities of DNA damage-based anti-cancer therapy.